His-Bundle Corrective Pacing in Heart Failure

His-Bundle Corrective Pacing in Heart Failure
PI: Valentina Kutyifa, MD, PhD, Roderick Tung, MD
University of Rochester Medical Center, Rochester, NY, and University of Chicago, Chicago, IL
Heart failure (HF) is a significant chronic health issue with the most prevalent cause of preventable
hospitalizations, linked to insurmountable health care costs. Cardiac resynchronization therapy
with a defibrillator (BIV-CRT) has been shown to improve outcomes of HF patients with severely
reduced left ventricular function, however it was shown to be less beneficial in a subset of patients
with right bundle branch block (RBBB) ECG morphology. His-bundle corrective pacing for cardiac
resynchronization (His-BIV) is an emerging technology that could be especially helpful in patients
with RBBB ECG pattern in whom BIV-CRT is less optimal. However, data are limited on the
efficacy and on the mechanism of action of His-CRT as compared to BIV-CRT. Therefore, we
propose a randomized mechanistic clinical trial to prospectively evaluate the efficacy and
mechanisms of His-CRT vs. BIV-CRT on electrical and mechanical resynchronization in 120 HF
patients with severely reduced left ventricular function, wide QRS, and RBBB ECG morphology.
The primary aim of this trial is to prospectively evaluate whether His-CRT is more effective
improving LV ejection fraction (LVEF) at 6 months than BIV-CRT in HF patients with RBBB.
Our secondary aim includes assessing the mechanism of benefit with His-CRT vs. BIV-CRT by
evaluating changes in ECG biomarkers, serum biomarkers, and echocardiography biomarkers.
Our tertiary aim is to evaluate the temporal development of the biological processes of electrical
and mechanical resynchronization with His-CRT vs. BIV-CRT, including temporal changes of
ECG biomarkers, NT-proBNP levels, and improvement in functional status and quality of life at 6,
12, and 24 months following device implantation with His-CRT as compared to BIV-CRT.
Safety assessment will include serious adverse events, implant procedure-related complications,
and evaluation of device and implanted lead parameters during follow-up.
Study population will include 120 HF patients with RBBB randomized to His-CRT vs. BIV-CRT in
a 1:1 ratio. We will be collecting echocardiography data at baseline and 6-month, and serial ECG
data at 6, 12, and 24 months, analyzed by central core laboratories. High-volume, experienced
centers with implanted device track records and research infrastructure will participate, with
implantation of His-CRT and BIV-CRT performed according to standard of care.

Public health relevance
His-Bundle Corrective Pacing in Heart Failure Heart failure patients with right bundle branch block (RBBB) ECG morphology have been shown to have a suboptimal response to biventricular cardiac resynchronization therapy (BIV-CRT), necessitating the identification of improved treatment strategies. His-bundle corrective pacing for cardiac resynchronization therapy (His-CRT) is an emerging innovative technology that provides more physiologic resynchronization than BIV-CRT, and could better treat patients with RBBB. In this randomized clinical trial, we will prospectively evaluate the efficacy and the mechanism of benefit of His-CRT vs. BIV-CRT by evaluating changes in ECG biomarkers, NT-proBNP, and echo biomarkers at 6 months, and by assessing the temporal changes in ECG biomarkers, NT- proBNP, functional status and quality of life at 6, 12, and 24 months of follow-up in 120 HF patients with right bundle branch block (RBBB) ECG morphology.